Hybrid Rat Diversity Program - cryopreservation resource for rat models

Project Summary
The ongoing goal of this program is to extend the use of rat models for clinical translation
through establishing an animal resource and genomic dataset to facilitate the translation of
laboratory research to clinical relevance. Specifically, the Hybrid Rat Diversity Panel (HRDP)
resource provides the research community with a foundation for systems genetics and a tool for
forward genetics. The HRDP parent award aims to 1) to continue to establish the 96 strain
Hybrid Rat Diversity Panel comprised of 33 classic inbred strains, 30 HXB/BXH recombinant
inbred strains and 33 FXLE/LEXF recombinant inbred strains through embryo rederivation and
importation, 2) to characterize, maintain and distribute the HRDP, 3) to provide genomic and
transcriptomic sequencing of the HRDP and 4) and provide data analysis, integration and
dissemination primarily through the Rat Genome Database (RGD). Specifically, this supplement
will 1) evaluate embryo quality pre- and post-cryopreservation, 2) improve the efficiency of
embryo collection for cryopreservation, and 3) develop cryopreservation protocols customized to
strain characteristics. Together these results will have broad utility the scientific community
through the genetic and phenotypic diversity represented in the strains selected for the
supplement project in combination with the available data from the HRDP parent award. Data
and protocols will be made available to the research community through the Rat Genome
Database, publications, and through rat repositories.

Public health relevance
Project Narrative This supplement to the HRDP R24 resource grant builds upon our existing infrastructure to develop the Hybrid Rat Diversity Panel (HRDP) through cryopreservation and rederivation of the inbred rat strains. This project will evaluate embryo quality using a standard approach, improve efficiency and quality through the development of new methods, and develop protocols to be distributed to the scientific community to assist in the more efficient cryopreservation and rederivation of rat models for biomedical research.